An HR-MAS H/F/X/Y UHF NMR Probe for Allosteric Drug Research at Physiological Conditions

An HR-MAS H/F/X/Y UHF NMR Probe for Allosteric Drug Research at Physiological Conditions
Abstract
More than a third of drugs in development include a fluorinated site, and a large fraction target allosteric
sites (for reduced side effects) in macromolecules. NMR is generally the most powerful tool for getting
essential chemical, functional, and dynamical information on drug-protein interactions, but conventional liquids-
NMR methods are not effective on large proteins. Fast-MAS ssNMR methods have produced spectra from
solid macromolecule samples with improved resolution, but Fast-MAS is not well suited for acquiring data at
physiological conditions, which is crucially important, particularly for drugs targeting allosteric sites. The
optimum method for acquiring high resolution (HR) NMR spectra from inhomogeneous samples – such as
tissues, or proteins solubilized in a bicelle or nano-disc in a saline hydrated lipid environment – at near-
physiological conditions is HR-MAS, which among other things requires larger sample volumes (because
concentration is so low) and ultra-low E fields during 1H decoupling at high fields. HR-MAS 1H NMR has
demonstrated resolution of 15 ppb on smaller peptides in bicelles and 4 ppb on various metabolites in cells.
However, HR-MAS probes with 1H/19F capability have apparently never been reported. Some H/F/X MAS
probes have been demonstrated up to 700 MHz, but the best resolution reported thus far in such is ~200 ppb.
For solution NMR on the other hand, four-channel multinuclear 1H/19F/X/2H probes are available to at
least 800 MHz, and such have proven to be extremely valuable for identification and characterization (using
1H/15N, 19F/13C, and 19F/2H/15N methods) of active fragments, their binding to soluble proteins, and their effects
on soluble protein-protein interactions. The problem is that such methods don’t work with insoluble proteins –
as involved in cancers, Alzheimer’s Disease (AD), Parkinson’s Disease (PD), and many others.
This Phase-I proposal seeks funding to develop, build, and test a prototype H/F/X/Y HR-MAS probe
with a novel rf circuit optimized for high-sensitivity 19F detection, with detection or simultaneous high-power rf
irradiation on any or all the other three channels for further narrowing beyond that usually seen in HR-MAS, as
MAS alone doesn’t average J-couplings. The probe will be suitable for HR-MAS – on liquids, semi-solids,
tissues, and solids – at fields from 7-28 T with rotor diameters from 1.3 mm to 3 mm.
The novel probe would allow the full suite of NMR acquisition and automated structure determination
protocols developed for solution NMR to be applied to fluorinated drugs targeting allosteric sites in
macromolecules. The Phase-I 3-mm probe is expected to achieve 5 ppb resolution at near-physiological
conditions, and the Phase-II probe ~3 ppb, or about two orders of magnitude better than prior published H/F/X
MAS data. The probe will be essentially devoid of problematic background signals for all the primary nuclides
(1H, 19F, 31P, 13C, 2H, 14N, and 17O), and it will be tunable to virtually all combinations of interest, thereby making
it also invaluable in such areas as metabolism, materials science, catalysis, and sustainable energy.

Public health relevance
An HR-MAS H/F/X/Y UHF NMR Probe for Allosteric Drug Research at Physiological Conditions Narrative Thousands of researchers are regularly using Nuclear Magnetic Resonance (NMR) techniques, with most of the applications driven by the need for structure and function determination in biological macromolecules and pharmaceuticals. The advances developed under this project will allow these laboratories to extend their methods to development of fluorinated drugs with fewer side effects for the treatment of cancers, Alzheimer’s Disease, and many other diseases.